Training Program in Translational Science, HIV, and Sexual and Gender Minority Health

Project Summary
Sexual and gender minorities (SGM) are heavily burdened by HIV in the U.S., including cisgender sexual
minority men, transgender women and men, and non-binary people assigned male at birth. SGM also
experience vast health inequities outside of HIV, including mental health problems, substance use, and various
physical health outcomes. Minority stressors (i.e., those unique to SGM) are linked to HIV-related outcomes
and mental health, driven by various biopsychosocial processes. Further, these health issues do not occur in a
vacuum; multiple, comorbid health-related issues interact synergistically to form a “syndemic” that drives HIV
incidence and HIV care outcomes among SGM. In order to rapidly address these issues, we need skilled
translational scientists who can delineate the mechanistic processes driving disparities, translate findings into
interventions, and implement programs with communities. Built on the infrastructure of Northwestern's Institute
for Sexual and Gender Minority Health and Wellbeing, the TrainingProgram in Translational Science, HIV,
andSexual and Gender Minority Health (NU-THRIVE)will support promising scientists in building the skills
necessary to understand these complex relationships and mitigate health disparities impacting SGM people,
including HIV. NU-THRIVE aims to train postdoctoral fellows in research methods across the Translational
Science Spectrum through a rigorous program in which they will: 1) specialize and gain depth of knowledge in
2 Translational Science Skill Domains (i.e., Quantitative Methods, Qualitative Methods, Interventions & Trials,
Implementation Science) through mentored research; and 2) gain breadth of knowledge in all 4 domains
through a formal training curriculum. NU-THRIVE will support 3 new postdoctoral fellows per year, on 2-year
appointments. We expect a majority will have a PhD (behavioral/social science) and a minority will be MD
physician-scientists. Fellows will select 1 Primary and 1 Secondary Mentor. Primary Mentors are faculty who
focus primarily on HIV, mental health, and/or SGM health. Secondary Mentors come from a range of
disciplines and have expertise complementary to the aims of NU-THRIVE but may work outside of or adjacent
to HIV and mental health among SGM. Fellows will gain knowledge and skills in 8 core competencies: 1)
translational science in HIV & SGM health; 2) biopsychosocial drivers of HIV, mental health, & associated
comorbidities; 3) developmental lifespan & environmental influences on HIV, mental health, & comorbidities; 4)
intersectional identities, HIV, & SGM health; 5) team science skills; 6) ethics & responsible conduct of
research; 7) writing, dissemination, & grantsmanship; 8) professional & career development. NU-THRIVE
training modalities will include mentored research activities, a didactic seminar series, intensive trainings in
translational science methods, structured writing support, and other activities available in the rich Northwestern
environment. NU-THRIVE will place fellows at the forefront of HIV and SGM health research, with the goal of
more rapidly moving basic science discoveries to efficacious interventions and onward toward implementation.

Public health relevance
Project Narrative The NU-THRIVE T32 program will train postdoctoral fellows in research methods in HIV, mental health, and SGM health across the Translational Science Spectrum. Fellows will engage in a rigorous training program in which they will: 1) specialize and gain depth of knowledge in two Translational Science Skill Domains (i.e., Quantitative Methods, Qualitative Methods, Interventions & Trials, Implementation Science) through mentored research with a primary and secondary mentor; and 2) gain breadth of knowledge in all four domains through a formal training curriculum. NU-THRIVE will place fellows at the forefront of translational science in HIV and SGM health, with the ultimate goal of more rapidly moving basic science discoveries to efficacious interventions and onward toward implementation.